Development and evaluation of an internet based adaptation of the New Beginnings Program for divorced parents

PROJECT ABSTRACT The proposed research builds on a successful Phase I SBIR grant to develop and test a web-based version of a parenting-after-divorce group intervention, the New Beginnings Program, which has been shown in two randomized trials to reduce youths’ problem behaviors and enhance their developmental competencies in the 15-year period after their parents participated. The proposed web-based format will increase the reach and consequently the public health impact of this evidence-based intervention. A commercialization plan is described to show how this program will be widely adopted and commercially successful.

Public health relevance
PROJECT NARRATIVE Evidence-based, group parenting skills interventions have been shown to promote healthy child development. Unfortunately, the public health potential of these interventions is severely limited by low parent participation rates that have resulted from barriers and accessibility constraints imposed by the group format. The goal of this application is to develop and test the efficacy of an electronic adaptation (eNBP) of the New Beginnings Program (NBP), a group-based parenting-after-divorce program that has been shown in two randomized trials to significantly enhance developmental competencies and reduce a wide range of youths’ problem behaviors in the 15-year period after their parents participated. Program benefits included improvements in grades and self- esteem, as well as reductions in substance use, mental health problems and high risk sexual behavior. Mediational analyses showed that program benefits were accounted for by improvements in the quality of post- divorce parenting (warmth, communication, discipline). The development of eNBP will provide an economical and highly accessible version of the NBP. The application builds on a successful Phase I SBIR that developed and pilot-tested a prototype of a web-based version of the first session of the NBP. Results from the pilot showed that the eNBP was highly acceptable to divorced parents and professional stakeholders. Importantly, there was a high rate of program completion, and parents who did the eNBP reported successfully using the skill that was taught. The current application will adapt all 10 sessions of the NBP into a web-based program. A randomized trial with 360 parents will test the efficacy of the web-based program as compared with a popular web-site for divorced parents by comparing effects on quality of parenting, interparental conflict and children’s social competence and problem behaviors at post-test and six months follow-up. Other web-based programs for divorcing parents focus primarily on strengthening co-parenting and reducing interparental conflict. The proposed web-based adaptation of the NBP is distinguished from existing programs by its focus on the quality of post-divorce parenting. The randomized trial of eNBP will be the first to examine the effects of a web-based program for divorced parents to strengthen the quality of post-divorce parenting and promote children’s socioemotional development and reduce their mental health problems. A commercialization plan describes how the program will be commercially successful.